A novel REverSe Transcriptase Chain Termination (RESTRICT) assay for near-patient, objective monitoring of long-term PrEP adherence

ABSTRACT
Oral pre-exposure prophylaxis (PrEP), composed of tenofovir disoproxil fumarate and emtricitabine, is effective
for preventing HIV acquisition, but PrEP efficacy is highly dependent on drug adherence. In several trials and
implementation studies, PrEP clients have difficulties maintaining adequate adherence and persistence, and
monitoring their PrEP use is challenging. PrEP providers have relied on self-reported adherence, which is often
inaccurate and unreliable. The lack of an objective PrEP adherence monitoring tool has led to inefficient
counseling and poor supportive care. To address these issues, we completed a randomized pharmacokinetic
study to determine drug levels during controlled directly-observed PrEP. Longer-term metabolites, such as
tenofovir-diphosphate (TFV-DP) (~17-day half-life), provide a more accurate picture of long-term PrEP
adherence. We recently developed a novel enzymatic assay that semi-quantitatively measures the concentration
of TFV-DP by measuring inhibition of reverse transcriptase, which is the cellular target of oral PrEP drugs. In this
proposal, our primary objectives are optimizing the REverSe TRanscrIptase Chain Termination (RESTRICT)
assay to measure drug concentrations of PrEP clients, to establish validation for CLIA criteria when implemented
in a near-patient clinical lab, and to evaluate the feasibility and acceptability of using the RESTRICT assay for
drug level measurement among PrEP clients and providers. We will test our central hypotheses with three
specific aims: (1) to calibrate and optimize the RESTRICT assay for measuring long-term TFV-DP drug
concentrations, compared to gold-standard liquid chromatography tandem mass spectrometry (LC-MS/MS)
measurement; (2) to validate the RESTRICT assay for meeting established CLIA criteria to enable clinical
reporting of an objective near-patient measure for monitoring long-term TFV-DP drug concentrations; (3) to
evaluate the feasibility and acceptability of near-patient TFV-DP testing among PrEP clients and providers at a
major PrEP clinic in Seattle. Our proposed study will be the first to validate a rapid, near-patient long-term
objective measure of oral PrEP adherence. This study will also provide crucial data on the feasibility and
acceptability of a novel approach for improving PrEP delivery and monitoring to prevent HIV transmission. The
results of this study will develop a new tool that may help improve PrEP delivery in the US and worldwide.

Public health relevance
PROJECT NARRATIVE The lack of an objective PrEP adherence monitoring tool has led to inefficient counseling and poor supportive care. We recently developed a novel enzymatic assay that semi-quantitatively measures the concentration of TFV-DP by measuring inhibition of reverse transcriptase, which is the cellular target of oral PrEP drugs. In this proposal, we will optimize the REverSe TRanscrIptase Chain Termination (RESTRICT) assay to measure TFV- DP concentrations in PrEP clients, validate the assay to meet CLIA requirements, and conduct a feasibility and acceptability study among PrEP clients and providers.